Effect of time-based energy intake goals on weight loss during obesity treatment.

PROJECT SUMMARY/ABSTRACT
Obesity is a complex disease, and innovative treatments that enhance initial and long-term weight loss are
needed. One novel treatment approach uses a biobehavioral framework, focusing on time-based energy intake
goals (how energy intake is distributed across the day). Time-based dietary goals are believed to promote
synchronization of biological and behavioral circadian rhythms, and determining the health benefits of these
goals is an objective of NIH’s nutrition strategic plan. Empirical testing of this time-based strategy is limited,
and what has been conducted has been short-term (< 3 months) interventions. That said, current findings
support that eating more energy earlier in the day and less energy later in the day increases weight loss during
obesity treatment. The effect usually starts early in treatment and increases over time, but sustained impact is
unexplored. One mechanism for this relationship is enhanced appetite regulation. Within a reduced energy
diet, goals that provide a morning-loaded energy distribution result in lower hunger, reduced desire to eat,
and/or greater fullness ratings than goals that provide an afternoon/evening-loaded energy distribution.
However, the relationship between appetite regulation changes and weight loss has not been examined.
Finally, chronotype, an individual’s preferred timing of daily activities thought to reflect circadian rhythms, may
moderate the effect of time-based dietary goals. No investigation has examined the influence of chronotype on
the relationship between distribution of energy intake and weight loss. To address these gaps, we will test the
more longer-term (12 months) effect of time-based energy intake goals on weight loss. We will explore if
enhanced appetite regulation is a mediator of the relationship and whether chronotype moderates the effect.
For this, 174 adults with overweight or obesity will be randomly assigned to one of three, 12-month lifestyle
interventions: 1) Morning (a morning-loaded energy distribution); 2) Evening (an afternoon/evening-loaded
energy distribution); or 3) Standard (no guidance on energy distribution). All conditions will receive the same
reduced-energy, low-fat dietary prescription, in which the guidance on the eating window length and the
number of eating occasions is identical; a physical activity goal; and a cognitive behavioral intervention.
Assessments will occur at 0, 3, 6, and 12 months on anthropometrics, diet (24-hr recalls with time-stamped
digital images verifying timing of intake, combined with continuous blood glucose monitoring to objectively
assess for length of the eating window and number of eating occasions), sleep regularity (actigraphy), appetite
regulation as assessed via ecological momentary assessment, and chronotype. We anticipate that Morning will
have the greatest percent weight loss, earliest midpoint of energy intake, greatest sleep regularity, and better
appetite regulation at 12 months. We will explore if appetite regulation mediates the relationship between time-
based energy intake goals and weight loss, and if chronotype moderates examined relationships.

Public health relevance
PROJECT NARRATIVE Obesity is a complex disease, and innovative treatments that use a biobehavioral framework, such as focusing on time-based energy intake goals (how energy intake is distributed across the day) may enhance initial and longer-term (12-month) weight loss. Time-based dietary goals are believed to promote synchronization of biological and behavioral circadian rhythms, and determining the health benefits of these goals is an objective of NIH’s nutrition strategic plan. This investigation is a randomized controlled trial designed to examine the effect of time-based energy intake goals on longer-term (12-month) weight loss, sleep regularity, and appetite regulation; if enhanced appetite regulation mediates the relationship with weight loss; and if chronotype moderates the effects.